The Exocrine and Endocrine Pancreas in Type 2 Diabetes, Pancreatitis and Cancer

PROJECT SUMMARY:
Type 2 diabetes, chronic pancreatitis, and pancreatic cancer are common and inter-related diseases that
require better approaches to diagnosis and treatment. N IDD K and NCI together formed a consortium of many
centers called CPD PC (chronic pancreatitis, diabetes and pancreatic cancer). Under the leadership of Santhi
Swaroop's Vege as the PI, the consortium is in the tenth year and now applying for the new 5 year cycle N IDD
K Grant, CP CRC (chronic pancreatitis clinical research consortium). During these 9 years, for the 3 main
studies PR OCE ED, DETECT and NOD, Mayo Clinic was at the top for recruitment of patients as well as for
the ancillary studies like MINIMAP, PAIR, and IMPACT. We also could plan and complete ancillary studies
which included salivary biomarker study, PAIR and IMPACT.
We are now applying for the third 5 year cycle which will involve acute recurrent pancreatitis and chronic
pancreatitis in adults at our center. We will try to full fill the goals and strategies of the C PCR C with regards to
ongoing recruitment of participants, follow-up of the large number of participants already in the study during the
first 2 cycles, continuing the collection of various bio specimens successfully as has been done for 9 years,
and new ancillary studies understanding the pathogenesis of the disease as well as clinical trials (2 planned 1
in diabetes and 1 in smoking and chronic pancreatitis).
In addition to the experienced PI and the co investigators who have all been involved in this consortium so far,
the two experience study coordinators who have done exemplary work towards the goals of the second cycle
of the consortium will form the team and work with the PI and co investigators. We have a well standardized
mechanism to identify new patients with acute recurrent pancreatitis and chronic pancreatitis, request them for
bio specimens, collection storage and shipment of those bio specimens to the central bio repository, frequent
discussions with the monitoring team and other coordinating centers, and participation in face-to-face meetings
by all the consortium centers when required.
A detailed proposal for all the 3 aims of recruitment, collection of bio specimens and planning new studies to
understand the pathogenesis including interventional trials is being submitted to N IDD K.
.

Public health relevance
PROJECT NARRATIVE The main aims are: 1. Identification and recruitment of adult patients with acute recurrent pancreatitis and chronic pancreatitis. 2. Collection of bio specimens from the participants including blood, saliva, urine, stool and when possible pancreatic juice. 3. A. Studying the differences between chronic pancreatitis with prior acute pancreatitis and the group without prior acute pancreatitis with regards to genetic, metabolic, immunologic markers, and quality of life. B. Conduct a Phase 2 randomized controlled trial of multiple daily insulin injections with continuous glucose monitoring versus automated insulin delivery for therapy of advanced diabetes (requiring complex insulin therapy in addition to other non-insulin antihyperglycemic medications) in CP. C. Pilot trial of smoking cessation in chronic pancreatitis.